Inflammatory Signaling and Regeneration in Zebrafish models of Retinal Degeneration

Project Summary
Inherited retinal degenerations (IRDs) are genetic diseases that lead to the progressive loss of
photoreceptors and the permanent loss of vision. Wild-type zebrafish regenerate photoreceptors
after acute injury by reprogramming Müller glia into stem-like cells that produce retinal progenitors.
This regenerative process fails to occur in zebrafish models of IRDs. This proposal will address the
critical unanswered question as to why zebrafish mutants with chronic inflammation fail to regenerate.
Our preliminary data show that Notch pathway inhibition can promote photoreceptor regeneration in
the zebrafish cep290 and bbs2 models of progressive degeneration and that immunosuppression
prevents photoreceptor loss. These results offer insight into the pathways that promote Müller glia-
dependent regeneration and the role of inflammation in photoreceptor degeneration. Our central
hypothesis is that in zebrafish models of retinal degeneration, chronic inflammation results in elevated
Notch and NF-kB signaling that restricts the regenerative response to acute injury. Evidence from the
literature and our preliminary data rigorously demonstrate that Notch signaling in Müller glia differs in
response to acute injury or chronic degeneration. Understanding the link between pro-inflammatory
signaling from microglia and Notch signaling in Müller glia has not been previously addressed.
Furthermore, our current understanding of how inflammatory cytokines signal through the NF-kB
pathway has only been studied in the context of wild-type animals. The proposed studies will provide
critical insight into the relationship between microglia and Müller glia regeneration in chronic disease.
We will use state-of-the-art sequencing technologies to identify Müller glia- and microglia-specific
changes in gene expression in cep290 and bbs2 models in order to elucidate the relationship
between inflammation and regeneration. We will also identify and test specific ligand-receptor pairs
to identify the mechanisms that maintain Notch signaling in the zebrafish degeneration mutants and
identify key factors that stimulate NF-kB signaling. Understanding the mechanisms that underpin
retinal regeneration in multiple zebrafish disease models will generate novel hypotheses that can
ultimately be translated into humans with retinal degenerative diseases.

Public health relevance
Project Narrative Methods to regenerate photoreceptors represents a major therapeutic goal for inherited retinal disease. Zebrafish have the capacity to regenerate lost neurons following acute injury but mutants with retinal degeneration do not regenerate. This proposal will address critical unanswered questions such as why zebrafish with chronic inflammation in diseased retinas fail to regenerate and to determine how inflammation regulates regeneration.